Molecular Tools Core

The goal of the Molecular Tools Core (MTC) is to provide biomolecular tools to the bioMT faculty to allow them
to better achieve their research goals. During the first funding period the MTC assisted over 200 researchers
within the greater biomedical community and played a central role in the advancement of the bioMT junior
research project leaders (RPL) to externally funded independent investigators. Our success is based on the
centralization of the equipment and expertise for providing high-quality purified proteins and other biomolecular
tools, dedicated laboratory work by our expert staff, as well as training of users in the utilization of state-of-the-
art instrumentation maintained within the core. To complement the expertise of our faculty Director, we recruited
a highly experienced Lead Scientist to oversee the operation of the MTC and to provide expert protein
biochemistry support and consultation. Her experience in protein production has served her well particularly as
a consultant, providing advice from sequence analysis to expression systems to purification protocols to both
experienced and novice users. We have established efficient pipelines for protein production in E. coli and
mammalian cells and optimized purification schemes. In collaboration with the Molecular Interactions and
Imaging Core (MIIC), we have developed protocols for biochemical and biophysical characterization and QA/QC
of the final products. Additionally, during phase 1, the MTC created a bioMT Service Center for chargeback
costs of supplies, media and reagents related to eukaryotic cell protein production starting October 1, 2020. In
the next funding period, we will continue to provide valuable resources to all four RPLs as detailed in Aim 1.
One vital feature will be the addition of standard methods for protein production using insect cell lines (Sf9, Hi5).
Aim 2 is to enhance the efficient operation of the core, streamlining the day-to-day operations and overall
throughput to better serve the research community. We will build on our collection of resources, including strains,
vectors, in-house produced enzymes and resins. As part of our phase II strategy, we will expand our throughput
capabilities with respect with construct design, cloning, expression screenings to rapidly identify protein targets,
reducing the burden of the bioMT investigators on protein production. As the number of users of the MTC has
expanded, it is imperative that we invest in the efficiency of the operation of the core and maintain a robust user
base as we transition to a cost-share center to guarantee sustainability. Another key element of our phase II
strategy is sustainability. As outlined in Aim 3, we will develop cost-recovery models. Faculty will not be charged
during phase II, but we will share quarterly usage with projected costs, so they can include costs in grant
submissions prior to phase III. Looking towards the future, the MTC will also support collaborative pilot projects
designed to nucleate multi-project grants. Overall, the phase II plan for MTC will continue to catalyze the success
of RPLs and other bioMT faculty, drawing our faculty together and laying the foundation for the Institute’s long-
term transition to COBRE independence.